Task X7: Preparedness for Testing NIAID Priority Vaccines for Infectious Diseases

The Evaluation and Testing Services (ETS) for Vaccines and Other Biologics for Infectious Diseases contract provides a variety of product development services from early feasibility studies through manufacture.